Attenuation of sepsis-induced microvascular permeability and inflammation with the GLP-1R agonist liraglutide.

Project Abstract
Sepsis is a critical problem around the world causing 20% of all global deaths. The lack of effective
therapeutics leaves critically ill patients with systemic organ dysfunction often caused by damage to the
vascular endothelium. The damage induces micro-vessel dysfunction and increased permeability. Increased
permeability can be attributed to tight junction and adherens junction disruption within endothelial cells. All
blood vessels are lined with a single cell layer of endothelial cells that regulate exchanges between the
bloodstream and the surrounding tissues and modulate inflammation. During sepsis, endothelial cells secrete
circulating inflammatory mediators such as monocyte chemoattractant protein-1 (MCP-1) which cause
upregulation of cell adhesion molecules that facilitate leukocyte trafficking and also MCP-1 also disrupts tight
junctions in endothelial cells. Given the widespread vascular inflammation and breakdown of endothelial tight
junctions in sepsis, therapeutic approaches to maintain and restore endothelial tight junctions is a compelling
treatment strategy. GLP-1R agonists have unexpected anti-inflammatory and permeability attenuation effects.
Preliminary in vitro studies suggest that the protective effects of the GLP-1R agonist, liraglutide, in sepsis are
mediated through microvascular endothelium. Pre-treatment of primary human lung microvascular endothelial
cells with liraglutide improved lipopolysaccharide-induced barrier dysfunction indicating important effects of
liraglutide in protecting the endothelial barrier. In Aim 1, I will define the ability of liraglutide to attenuate
microvascular permeability in vitro and in a clinically relevant murine model of polymicrobial abdominal sepsis.
Additionally, in my preliminary studies, treatment of wild type mice with the GLP-1R agonist liraglutide
significantly decreased plasma MCP-1, attenuated organ injury, and increased survival in a model of
polymicrobial abdominal sepsis. MCP-1 secretion is regulated by p38 MAPK pathway activation. Interestingly,
GLP-1R agonists regulate the activation of MAPK. Therefore, there is rationale that liraglutide inhibits MCP-1
secretion via MAPK regulation. MCP-1 attracts monocytes to the site of inflammation, but also promotes their
adhesion by inducing them to upregulate ICAM-1 that is expressed in the activated endothelium. My
preliminary data suggests that liraglutide decreases endothelial ICAM expression in vitro. These adhesion
molecules allow the attachment of leukocytes to the endothelium and permit their transmigration into peripheral
tissue. In Aim 2, I will define the mechanism by which Liraglutide restores the endothelial barrier through
downregulation of MCP-1 and the subsequent leukocyte recruitment and tight junction and adherens junction
stability. Completion of these aims will determine whether liraglutide attenuates sepsis-induced microvascular
permeability and how liraglutide is vasculoprotective through an anti-inflammatory mechanism. This proposal
will promote advancement of an endothelial targeted drug to treat sepsis and further my goal to become an
independently funded principal investigator studying the mechanisms of endothelial injury in sepsis.

Public health relevance
Project Narrative Sepsis induces increased micro-vessel permeability and inflammation which ultimately contributes to end organ damage and high morbidity and mortality. Here, we present the GLP-1R agonist, liraglutide’s ability to attenuate sepsis-induced endothelial permeability through a novel anti-inflammatory mechanism.